Improving Population Health Through Enhanced Targeted Regional Decision Support

Project Summary/Abstract Comprehensive clinical information from a broad set of data sources is required for many healthcare tasks, including comparative effectiveness research, improving clinical care processes, and improving overall population health. Health information exchanges (HIEs) are an emerging source of healthcare data aggregation and comprehensive clinical data for these purposes. It is well-known that traditional clinical care processes underreport population level disease burden for a variety of reasons: reporters are overburdened or under resourced and they lack knowledge and/or willingness; and clinical data is scattered across different systems in different formats, which makes completing reports burdensome. Incomplete reporting can lead to inaccurate assessment of the disease burden in a community, which further hinders population health interventions and only partially informs preventive care delivered to individual patients. Our long-term goal is to improve population health through innovative informatics strategies that seamlessly integrate and effectively use practice-based population health tools in clinical care. The objective in this project is to improve the effectiveness of acute and preventative care processes by improving information sharing and data quality among healthcare providers and population health stakeholders using novel decision support tools. These tools will deliver reminders to clinical providers using pre-populated reportable condition forms that contain patient demographics and pertinent case management information. Further, this research will investigate the process and effects of deploying a framework to integrate HIE data captured from present and previous clinical encounters to improve the identification and reporting of conditions of population health significance. The central hypothesis of this proposal is that automated data capture and information enhancements will streamline provider-based population health reporting workflows, lower barriers to reporting and case follow-up, increase data completeness, capture a greater portion of communicable disease burden in the community, and improve population health. While this project focuses on the impact of novel population health decision support technology, the framework is applicable to a variety of use-cases. Thus, findings from this project will inform future large-scale clinical decision support initiatives in heterogeneous technical settings. We propose to employ both quantitative and qualitative research methods to determine the data elements and data characteristics vital for clinician case reporting, public health consumption of these reports and bidirectional transmission of case reporting information among population health stakeholders.

Public health relevance
Project Narrative The objective of this proposal is to improve the effectiveness of acute and preventative care processes by streamlining information sharing and enhancing information quality among healthcare providers and population health stakeholders using novel decision support and clinical messaging tools. The central hypothesis of this proposal is that automated data capture and provider alerts will improve time-to-treatment, simplify provider-based population health reporting workflows, and result in a more accurate assessment of population-based disease burden. __SpecificAimsTextDelimiter__ A. Specific aims Comprehensive clinical information from a broad set of data sources is required for many healthcare tasks, including comparative effectiveness research, improving clinical care processes, and improving overall population health. Health information exchanges (HIEs) are an emerging source of comprehensive clinical data for these purposes. It is well-known that traditional clinical care processes underreport population level disease burden for a variety of reasons: reporters are overburdened or under resourced and they lack knowledge and/or willingness; and clinical data is scattered across different systems in different formats, which makes completing reports burdensome.1,2 Incomplete reporting can lead to inaccurate assessment of the disease burden in a community, which further hinders population health interventions and only partially informs preventive care delivered to individual patients. Our long-term goal is to improve population health through innovative informatics strategies that seamlessly integrate and effectively use practice-based population health tools in clinical care.3 Our objective in this project is to improve the effectiveness of acute and preventative care processes by improving information sharing and data quality among healthcare providers and population health stakeholders using novel decision support tools. These tools will deliver reminders to clinical providers using pre-populated reportable condition forms that contain patient demographics and pertinent case management information. Further, this research will investigate the process and effects of deploying a framework to integrate HIE data captured from present and previous clinical encounters to improve the identification and reporting of conditions of population health significance. The central hypothesis of this proposal is that automated data capture and enhancements will streamline provider-based population health reporting workflows, lower barriers to reporting and case follow-up, increase data completeness, and capture a greater portion of communicable disease burden in the community. While this project evaluates novel population health decision support technology, the framework is applicable to a variety of use-cases. Thus, findings from this project will inform future large-scale clinical decision support initiatives in heterogeneous technical settings. We propose to employ both quantitative and qualitative research methods to determine the data elements and data characteristics vital for clinician case reporting, public health consumption of these reports and bidirectional transmission of case reporting information between public health and healthcare providers through the following Specific Aims. Specific Aim 1 We will evaluate the process and operational outcomes of deploying an advanced technical framework and methodology in the context of a long-standing operational HIE that enhances management of population-level notifiable condition reporting and bidirectional communication among providers and population heath stakeholders using decision support tools. To characterize the performance of this intervention we will use a variety of metrics, including reporting completeness and timeliness, time-to-treatment, and communication efficiency. Specific Aim 2 We will evaluate the quality of existing healthcare data and the capacity of an advanced technical framework to enhance data quality by measuring baseline, pre-implementation and post-implementation data quality statistics including accuracy, completeness and timeliness for provider and patient demographic information, and additional relevant clinical data. We will describe methods for improving data quality using HIE components and assess their effectiveness. Specific Aim 3 We will identify and assess facilitators and barriers - including social, behavioral and environmental - that are associated with the implementation and utilization of an advanced technical framework both within single organizations and across multiple organizations within an HIE.